Amplifying the Value of HuBMAP Data Through Data Interoperability and Collaboration

The Human BioMolecular Atlas Program (HuBMAP) is developing a comprehensive baseline for normal
(healthy) tissue. This baseline will have great value, but only through comparison of complementary
datasets against it. We propose accelerating research to be based on the interoperation of HuBMAP data
with complementary datasets through a two-year Common Fund Data Ecosystem (CFDE) project. In this
project, HuBMAP will: 1) partner closely with the CFDE Coordinating Center (CFDE-CC) on CF-wide data
activities, and 2) engage in pilot projects with two other Data Coordination Centers (DCCs) – Stimulating
Peripheral Activity to Relieve Conditions (SPARC) and Gabriella Miller Kids First – to demonstrate the value
of establishing interoperability between appropriately chosen datasets.